An Integrative and Collaborative Genomic Data Analysis Service with Galaxy

Project Summary Galactic Core LLC aims to develop a robust, scalable, and managed service for performing enterprise-grade biomedical data analysis. The service will be based on the popular open-source Galaxy application (?https://galaxyproject.org/?), offering managed data storage and compute resources with an extremely powerful, flexible, and collaborative environment for analyzing biomedical data. The service will be run as a set of private environments with dedicated computers being setup and managed for research teams performing data analysis. Data generation assays and analysis tools in the Biomedical Sciences continue to evolve rapidly and fixed 1-click approach to data analysis is very challenging as the analysis must be quickly adapted to new methods and types of data. This landscape requires a proportionally vast and growing amount of capacity for data analysis that can be readily tailored to the domain and integrates with an array of external resources. Galaxy with its accessible web-interface and a worldwide community is uniquely positioned to adapt to this changing landscape as it provides access to >6,500 best-of-breed analysis tools and >100 data types. These numbers are unmatched by any similar solution, yet the rate at which tools and data types are added into the Galaxy ecosystem continues to increase. However, the challenges with setting up, maintaining, and evolving the necessary data analysis environment present an obstacle for biomedical data analysis, particularly for small firms and laboratories. The goal of this project is to streamline the process of setting up and managing a production-quality instance of Galaxy and deliver it as a scalable, managed, always-on service. Broad and simple availability of a powerful biomedical data analysis platform would fundamentally improve access to biomedical data analysis capacity and facilitate routine analyses by research labs and small businesses.

Public health relevance
Project Narrative The popular Galaxy application ( https://galaxyproject.org/ ) is uniquely positioned to address the continuously evolving biomedical data analysis needs because it integrates and provides ready-access to thousands of best-of-breed analysis tools and data types. However, the software and compute resources available to the Galaxy application require an elaborate setup and must be responsive to the specific user requirements. The goal of this project is to offer a managed, accessible, cloud-based instance of the Galaxy application that can be readily installed and managed to meet the needs of data analysis groups.